Activity-related mechanisms of selective retinal ganglion cell resilience and axon regeneration

Project Summary
Retinal ganglion cell (RGC) degeneration underlies vision loss following traumatic injuries and in optic
neuropathies like glaucoma. Treating these conditions requires interventions that promote RGC
neuroprotection and axon regeneration. While many such treatments have been identified in pre-clinical animal
models, none promote recovery, and typically treatment effects are limited to a small subset of RGCs. To
bridge the gap in understanding why treatments have incomplete effects, we took the approach of resolving
how axonal injury affects distinct RGC types and how each RGC type responds to regenerative interventions.
This approach revealed that RGC resilience and axon regeneration are highly cell type-dependent and
associate with high RGC activity levels. In this proposal, we will explore the mechanistic connections between
cell type-specific RGC activity, resilience, and axon regeneration.
Neuronal activity mediates numerous cellular processes that could influence injury response including
immediate early gene expression, cAMP signaling, and Ca2+ dynamics. Indeed, increasing RGC activity by
neuromodulation promotes RGC survival and axon regeneration. However, we have limited insight into how
these approaches will work across RGC cell types, which have distinct functional properties and participate in
different neural circuits. Our experiments will employ cutting-edge multidisciplinary approaches to dissect the
molecular and physiological effects of neuromodulatory treatments on different RGC types. We will first
examine a signaling pathway mediated by Urocortin (UCN) and Corticotropin-releasing hormone (CRH), which
we recently discovered to promote RGC resilience and axon regeneration after axonal injury. UCN/CRH are
neuropeptides that increase neuronal excitability, but their function in RGCs and the mechanisms underlying
their neuroprotective and regenerative effects are unresolved. We will investigate both the native roles of
UCN/CRH in shaping RGC physiology and the effects of activating UCN/CRH signaling on mitigating RGC
injury response. Next, we will test the effects of increasing or decreasing RGC activity on injury response by
silencing RGC pre-synaptic inputs or by directly altering RGC membrane potential. Our work will be the first to
characterize the combined effects of injury and activity across cell types of a diverse neuronal population. We
will gain mechanistic insight into the connection between high RGC activity and selective resilience and axon
regeneration after injury. Our studies have strong potential to improve approaches for the treatment of RGC
degeneration and are also likely to elucidate generalizable principles mediating neuronal survival and axon
regeneration that will have implications for other neurodegenerative conditions.

Public health relevance
Project Narrative Retinal ganglion cell degeneration underlies vision loss in traumatic injuries and optic neuropathies like glaucoma. Strategies to promote retinal ganglion cell neuroprotection and axon regeneration remain an unrealized clinical goal. This project will deeply explore cell-type specific activity-related mechanisms mediating retinal ganglion cell survival and growth after axonal injury.